The Role of Monoallelic Expression in Incomplete Penetrance of Primary Immunodeficiencies

Project Summary:
Primary immunodeficiencies (PIDs) are monogenic disorders of the immune system. PIDs affect 1 in 780
hospitalized children. Incomplete penetrance of PIDs is common and remains largely unexplained. Herein I
hypothesize that incomplete penetrance in PIDs may also be explained by monoallelic expression (MAE).
Traditionally, transcription of autosomal genes is thought to occur from both inherited genes. Recent studies
indicate that up to 10% of autosomal genes can randomly commit to gene expression from a single allele,
termed monoallelic expression. Unlike X-inactivation or imprinting, MAE is independent of other genes and
leads to a diverse population of cells at the transcript level. The existence of MAE of PID genes is unknown.
Families with mutations in JAK1 or PLCG2 exhibit incomplete disease penetrance. My preliminary data
suggests that both JAK1 and PLCG2 can undergo MAE. Within this proposal I aim to 1) Map MAE of PID
genes in primary immune cells and 2) evaluate the functional impact of monoallelic expression in JAK1
and PLCG2 ex vivo. The findings of this proposal will inform the biological study and clinical genetics of PIDs
by identifying thresholds of transcript diversity which drive disease penetrance. In addition, these findings will
provide a framework for similar work in other genetic diseases, while setting a foundation for mechanistic
studies directed at the control of MAE as a therapeutic for monogenic disease.

Public health relevance
Primary Immunodeficiencies (PIDs) are inborn errors of the immune system, affecting 1:780 hospitalized children. Despite widespread incomplete penetrance leading to difficulties in the study and clinical management of these diseases, we have a very limited understanding of the factors that drive phenotypic variability. This proposed study will uncover PID genes that are regulated by monoallelic expression (MAE) and the impact the resulting transcriptional heterogeneity has on disease penetrance, setting the foundation for future work aimed at manipulating MAE to reduce the burden of PIDs on child health.